Administrative Core

Core A: Project Summary/Abstract
The Administrative Core (Core A) will provide the operational support for the management, coordination and
supervision of the overall program. Core A serve as the central mechanism for the collection and dissemination
of data, financial information and feedback between Project and Core leaders. The Administrative Core will also
coordinate and oversee all meetings between NIAID Program Officials, the Scientific Advisory Board, internal
advisors, and Project and Core leaders to maintain open lines of communication and accountability. In these
ways, Core A will ensure that this collaborative research effort proceeds with maximum productivity and meets
all regulatory requirements.